Multisystem Stress Response Biotypes: Deriving Novel Physiological and Neural Risk Factors for Anhedonia in Adolescence

PROJECT SUMMARY
Anhedonia (ANH), the reduced ability to anticipate or experience pleasure, is a major transdiagnostic contributor to
disability, inferior quality of life, and a core characteristic of multiple severe psychopathologies. ANH emerges in
adolescence prior to the onset of these disorders and is highly prevalent (up to 20%) in youth 13-15 years. However, ANH
in adolescence is poorly understood and interventions remain few. A growing body of evidence suggests that stress
exacerbates ANH and dysregulated acute stress response mechanisms may critically contribute to ANH. Yet, little is
known about the role of stress neurobiology in the emergence, course, and severity of ANH in adolescence, a critical
developmental period marked by significant pubertal changes and steep maturation of neural circuits implicated in the
recalibration of the stress-response systems and mood regulation.
The objective of the current proposal is to characterize how biological acute stress response mechanisms influence the
severity and trajectory of ANH. ANH research to date has almost exclusively focused on single-system physiological
responses to acute stress, such as autonomic nervous system (ANS - parasympathetic and sympathetic nervous system
branches - PNS-SNS) or endocrine (HPA - Hypothalamic Pituitary Adrenal) system responses. New evidence supports the
need for multi-system approaches to detect clinically meaningful patterns of stress responses associated with ANH.
Recent research from our labs (PI Belger and Co-PI Roubinov) has shown that (1) discrete physiological latent stress-
response profiles (Buffered, Vigilant, Sensitive) that integrate unique patterns of responses across HPA and ANS systems
have additional utility in predicting both clinical and functional development outcomes beyond single-system biomarkers.
In this proposal, we will examine how a novel constellation of complex neurobiological stress response mechanisms
interactively contributes to ANH in adolescence. Using a multimodal approach including functional MRI (Magnetic
Resonance Imaging), physiological HPA and ANS stress reactivity, and clinical and cognitive assessments, the proposed
study will be the first to integrate physiological and neural acute stress response mechanisms to derive multisystem stress
response biotypes (MSRB) and explore their contributions to ANH severity and trajectory in adolescence. We will study
192 adolescents ages 13-15 years experiencing a range of ANH at baseline, 10 months, and 20 months across 2 aims. In
Aim 1 we will identify multisystem stress response biotypes (MSRBs) integrating physiological and neural responses to
acute stress in adolescents and examine their longitudinal stability. In Aim 2, we will determine the characteristics of
multisystem latent stress profiles that predict the severity and trajectory of ANH in adolescence. Across both aims, we
will examine age, sex, and pubertal stage as covariates.
IMPACT: This project will contribute a novel framework for understanding and modeling the complex multisystemic
biological mechanisms governing stress responsivity during adolescence. Understanding the individual and interactive
contributions of physiological and neural systems to ANH presents a unique opportunity to develop specific interventions
that target malleable stress systems in adolescents with ANH.

Public health relevance
NARRATIVE Anhedonia, the inability to anticipate or experience pleasure, emerges in adolescence, often heralds the onset of more severe psychopathology such as mood disorders and psychosis, and remains poorly understood. Atypical stress response and related dysregulation of neurobiological mechanisms have been proposed as key contributors to anhedonia. The proposed project will examine the individual and interactive roles of physiological and neural mechanisms associated with acute stress experiences to the severity and maturational trajectory of anhedonia in adolescence, thereby potentially informing the development of novel prevention and intervention strategies.